Placental epigenetic mechanisms contributing to sex-specific impacts of maternal stress on fetal development

Defining the mechanisms by which stress in the environment during pregnancy promotes changes in
development is critical in identifying factors predictive of disease risk or resilience. One major consistency
across prenatal insults is the increased vulnerability of males. In this proposal, we utilize our mouse model of
early prenatal stress (EPS) to examine sex-specific placental transcriptional regulation. In our EPS model,
male, but not female, offspring present with increased stress sensitivity, including increased HPA stress axis
activity, reduced post-weaning growth, and hypothalamic mitochondrial dysfunction. Sex differences in the
placental function are likely to produce sex-specific transplacental signals to the developing fetal brain. Sex
differences in the placenta begin with sex chromosomes. Through a genome-wide screen following maternal
stress, we identified the X-linked gene, OGT, as causal in programming the male-specific stress phenotype via
its regulation of the histone transcriptional repressive mark, H3K27me3. This proposal uses innovative
approaches to determine the mechanisms by which the female placenta is able to restrict transcriptional
responses to stress in the environment, where males are not, thus placing the male developing brain at greater
risk prenatally. The transplacental signals received by the developing brain appear to be related to energy
availability and impact metabolic and mitochondrial programming. Of key translational importance, we have
also found the same biochemical and molecular outcomes are predicted by fetal sex in human placental tissue.
Therefore, our proposal will focus on defining the causal importance of H3K27me3 in risk for developmental
changes in response to stress, identify the sex-specific transplacental signals resulting from these changes in
placental function using ex vivo perfusion, and determine the cellular compartment and mechanism by which
these changes promote hypothalamic mitochondrial reprogramming and the EPS phenotype.

Public health relevance
Defining the mechanisms by which maternal stress during pregnancy promotes changes in development is critical in identifying factors predictive of disease risk or resilience. One major consistency across prenatal insults is the increased vulnerability of males. We have identified a sensitive period of early gestation where maternal stress has sex-specific long-term programming effects on offspring development and function. We previously identified placental OGT as involved in programming this stress-sensitive phenotype in males via its regulation of the histone repressive mark, H3K27me3. In the current proposal, we will determine the epigenetic mechanisms by which stress in the environment alters placental function, identify the specific transplacental signals relayed to the fetus, and identify the cellular compartment and mechanism whereby mitochondria in the fetal brain are reprogrammed.